Education on Gender and Sex

ABSTRACT
Sexual and gender minority (SGM) individuals face dramatic health inequities in general, especially among
racially/ethnically diverse SGM living in the Deep South, home to the country’s largest SGM population.
Despite dramatic shifts in the political and social acceptability of SGM people across the United States,
progress remains tenuous in the Deep South, where there is pervasive stigma and discrimination. Further,
there are few health research training programs that view sex and gender through a wider, multifaceted lens,
inclusive of sexual orientation and gender identity, and none are located in the Deep South. Our overarching
goal is to train graduate students enrolled in health-related degree programs (e.g., public health, social work)
with an interest in health research to increase knowledge and advocacy skills addressing SGM health. We will
achieve that goal through creating and implementing a 4-year sex and gender program in SGM health,
GenderS (Education on Gender and Sex). We have built a unique community-academic partnership to lead
the GenderS program, including Dr. Emma Kay, founding director of the Magic City Research Institute, one of
the few research institutions in the Deep South housed within a community-based organization; and Dr. Sarah
MacCarthy, inaugural holder of the Magic City LGBTQ Health Studies Endowed Professorship, one of the few
positions nationally focusing exclusively on SGM health. Our specific aims include: 1) Develop GenderS, a
hybrid advocacy and community-based education program that addresses core concepts and hyperlocal
approaches to gender and sex in health; 2) Increase knowledge of and advocacy for SGM health via
implementation of GenderS; 3) Disseminate a GenderS Toolkit nationally to enable local adaptations,
implementation, and evaluation. Year 1 includes development of an online 14-week course covering core
concepts in SGM health, providing a foundational understanding of factors driving SGM risk and resilience with
attention to intersectional identities (e.g., age, ability, and race/ethnicity). The course will be complemented by
hyperlocal approaches, including an in-person 1-week residency highlighting knowledge and expertise among
community partners and a 6-month period of virtual mentoring and networking salon sessions. Years 2 and 3
include recruitment of two, 1-year cohorts (n=5-7 scholars per cohort) and implementation of the GenderS
program. Year 4 includes the development and national dissemination of a toolkit with guidance on how others
can develop, implement, and evaluate their locally adapted version. Our rigorous evaluation plan consists of
pre/post surveys to assess scholars’ mastery of topics taught in the online course, as well as interviews with
scholars and surveys with program mentors and faculty/community partners to assess opportunities for
program improvement. Through national dissemination of the toolkit, GenderS will be broadly available;
supporting tools will enable organizations to create locally-relevant experiences for future scholars to further
their understanding of sex, sexual orientation, gender, and gender identity influences on SGM health.

Public health relevance
NARRATIVE Despite the dramatic health inequities faced by sexual and gender minority (SGM) individuals, there are a dearth of training opportunities in general, and especially in the Deep South. Over 4 years, we will develop and implement a one-year training program for graduate students pursuing careers in health research, GenderS (Education on Gender and Sex), to synthesize SGM health content, develop concrete advocacy skills, and facilitate transparent dialogues regarding the systems and structures that limit SGM experience in the Deep South. Led by a unique community-academic partnership, and refined by rigorous evaluation and strategically disseminated to have national reach, the GenderS program will demonstrate to future investigators in health research how leaders from diverse backgrounds can work together to improve SGM health.